BIOLOGICAL AND CULTURAL FACTORS ASSOCIATED WITH LACTATIONAL DYSFUNCTION IN OVERW

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The objective of this study is to identify explanations for poor lactational performance in obese women using a bio-cultural approach.